1/2 Cherokee Nation/OSU and SCC Collaborative Partnership for Cancer Research

Abstract
Cancer disparities continue to impact the tribal nations within Oklahoma disproportionately. The proposed
Cherokee Nation/Oklahoma State University (OSU) and Stephenson Cancer Center (SCC) Collaborative has
four specific aims to achieve its overall mission of developing durable capacity in the context of an American
Indian tribal nation for research on cancer disparities:
1. to strengthen administrative infrastructure, including a joint Internal Advisory Committee, capable of
integrating research, research education and outreach efforts among the Cherokee Nation, OSU and
the SCC;
2. to conduct innovative pilot research in tobacco use and cancer risk capable of seeding large-scale
research projects performed in the Cherokee Nation setting;
3. to train the next generation of cancer researchers prepared to engage meaningfully with the Cherokee
Nation and other tribal nations in the context of this research, focusing on early-stage investigators
(ESIs), graduate, professional, and undergraduate students; and
4. to evaluate our work in order to optimize the impact of pilot research projects and cancer research
education and outreach activities, and guide continued expansion of Collaborative activities to address
cancer disparities.
Our excitement about the Collaborative centers on the opportunity to expand tribal capacity for cancer
disparities research through a coordinated program of pilot research directly involving ESIs and students in
scholarly work to address cancer disparities, particularly those resulting from tobacco, and through specific
cancer research curriculum development and outreach activities. The addition of OSU, which has remarkable
assets in the education and training of American Indian students and ESIs, including a new medical school
created in partnership with the Cherokee Nation, provides a unique environment in which a tribe, a university
serving large numbers of AI students, and a research-intensive cancer center will work collectively to reduce
the unacceptable burden of cancer that continues to affect far too many AI people.

Public health relevance
Narrative. American Indian tribal communities suffer disproportionately from cancer disparities. This planning grant will expand authentic tribal capacity to address cancer disparities through a coordinated program of jointly executed pilot research directly involving early-stage investigators and students, and through specific cancer research curriculum development and outreach activities.